Center for Appalachian Research in Environmental Sciences-Administrative Core

PROJECT SUMMARY – Administrative Core
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UK-CARES)
Administrative Core will coordinate, oversee, and evaluate all programmatic and scientific activities and lead
cross-disciplinary career development initiatives, while providing and receiving support from the Integrated
Health Sciences Facility Core, the Analytical Chemistry Core for Environmental Sciences, the Community
Engagement Core, the Pilot Project Program, and our community partners. The Administrative Core leadership
is comprised of highly regarded senior scientists and research mentors who are well qualified to operate an
Environmental Health Sciences Core Center (EHS CC) that is responsive to the concerns of people in rural
Appalachia and to advance EHS across the translational spectrum. The Administrative Core will actively
collaborate with all Center members, community and academic, promoting their research and involving them in
Center decision-making and strategic programmatic activities, as well as engaging with other UK Centers and
EHS CCs. The organizational structure of UK-CARES will allow for optimal multidirectional Center-Community-
University communications and institutional support. Three Advisory Boards will inform our research, provide
advice and support, help us form and maintain robust community-academic partnerships, and evaluate
program progress: 1) a 12-member Stakeholder Advisory Board representing higher education, environmental
justice groups, healthcare, and public health in rural Appalachia; 2) an Internal Advisory Board comprised of 10
high-level campus and community decision makers; and 3) a 4-member External Advisory Board of prominent
national leaders in EHS. The Administrative Core has four Aims to: 1) coordinate, monitor, and evaluate the
Center’s scientific and programmatic activities; financial oversight and regulatory compliance; productivity; and
effectiveness as intellectual needs change; 2) facilitate internal multidirectional communication and responsible
conduct of research; 3) facilitate external multidirectional communication; and 4) cultivate careers in EHS with
a focus on underrepresented minority faculty. The Core will ensure effective internal and external
communications by directing monthly Executive Committee meetings; coordinating an Annual Scientific
Retreat, monthly scientific work groups with Center members, and a seminar series; and partnering with key
community and state partners via social media, our website, and other scientific and professional venues. The
Core’s Career Development Program will recruit and support early-stage investigators (ESIs) to become
independent EHS researchers and facilitate established investigators to transition to an EHS research focus
through maximizing the use of Center services, cross-disciplinary activities, and mentorship. Career
Development Program funding will support independent investigators newly recruited to UK, from outside UK-
CARES, or Center member ESIs with partial salary support. In the first cycle, the Administrative Core has
grown the Center as a recognizable entity in EHS and public health in rural Appalachia.